A Web-based Digital Health Portal for Practitioners to Improve Clinical Care and Patient Outcomes for Upper-limb Myoelectric Prosthesis Wearers

7. PROJECT SUMMARY / ABSTRACT
Coapt, LLC and Liberating Technologies, Inc, along with clinical collaborators at the Shirley Ryan
AbilityLab, will systematically develop and evaluate a connected health system for data collected from
upper limb prosthesis wearers using myoelectric control. The system will record wearer data relating
to their daily prosthesis use and functional performance outside the clinic directly from the prosthesis
hardware and through a mobile app which includes virtual game evaluation tasks. These data will be
uploaded to our existing cloud storage platform, where cloud computing algorithms will analyze and
highlight unique trends to provide the patient’s clinician with actionable insights that enable them to
much more easily identify where to focus their therapeutic efforts in a user-friendly, web-based digital
health portal, called the Clinician Dashboard.
The objective of this effort is to improve the standard of care in upper limb prostheses by developing
a commercially viable web portal which interfaces with Coapt’s existing state-of-the-art prosthesis
controller, which is compatible with 400+ combinations of powered hand, wrist and elbow devices.
This project builds on our preliminary development of a connected health system to (Aim 1) refine a
web-based Clinician Dashboard prototype by adding cloud-based analysis of prosthesis use and
performance data using an implementation science-informed design process, and (Aim 2) evaluate
efficacy of the Clinician Dashboard in improving rehabilitation outcomes for new upper limb
myoelectric prosthesis wearers. A formal participatory design process with key stakeholder (clinicians,
patients, and technological experts) input, surveys, and usability assessments will be used to
systematically inform the design and desired content of the Clinician Dashboard. We expect the
Clinician Dashboard will assist clinicians in their clinical decision making for delivering more effective
therapy which will, in turn, improve patient outcomes and accelerate their rehabilitation progress.
The outcomes of this project will be results from a pilot clinical trial evaluating the efficacy of the
Clinician Dashboard demonstrating improved rehabilitation outcomes which will support commercial
deployment and marketing of our connected health system. This product will directly address an
important clinician need that will be integrated into clinical practice to benefit the end-user - individuals
with limb loss/absence who opt to use a myoelectric-controlled prosthesis. Our connected health
system aims to improve functional outcomes and ability to complete activities of daily living (ADLs),
increased prosthetic use and device satisfaction, and overall improved quality of life.
Access to the Clinician Dashboard as part of a connected health system will be a distinctive feature
of Coapt’s Complete Control system which we expect to also drive sales over our competitors.

Public health relevance
8. PROJECT NARRATIVE This project will develop and evaluate a connected health system for upper limb myoelectric pattern recognition-controlled prostheses in which data collected from wearers during everyday prosthesis use and while using a mobile application will be stored in the cloud. The cloud-connected data will be processed using cloud computing tools and presented in a web-based data portal to provide clinicians actionable insights and suggestions for assessments and interventions. Access to objective measures of wearers’ daily prosthesis use and performance will assist clinicians in their clinical decision making towards delivering more effective therapy which will improve rehabilitation outcomes for wearers.